GENETIC AND NEUROENDOCRINE FACTORS IN AUTOIMMUNE DISEASES

BACKGROUND: A substantial body of data indicates that neuroendocrine factors play a role in the expression of autoimmune diseases such as rheumatoid arthritis (RA). A detailed understanding of these factors should provide important insights into the prevention and therapy of these diseases. We have been conducting studies addressing the role of hypothalamic-pituitary-adrenal (HPA), -gonadal and sympatho-adrenal axes in RA and other forms of early synovitis. We have previously investigated circadian secretion of ACTH, cortisol and interleukin- (IL)6 in RA patients compared to age-, gender-, and race-matched controls. Overall, ACTH and cortisol secretion were similar in patients and controls, except that RA patients exhibited higher early morning secretion. However, RA patients exhibited substantially higher plasma IL-6 levels. Our data suggest that HPA axis responses are "inappropriately normal" in RA patients. These patients appear to have a relative insensitivity to IL6-stimulated HPA axis activation. OBJECTIVE: We are doing followup studies by examining a much larger cohort of patients with various forms of early synovitis. Since deficient HPA function probably has pronounced effects on immune function, we are interested in evaluating this hypothesis. RESULTS. We have continued to explore the effects of cortisol and other stress mediators on TNF-alpha, IL-12 and IL-10 production by LPS-stimulated blood monocytes, particularly in the context of pregnancy and the postpartum periods. TNF-alpha and IL-12 are prototypic proinflammatory cytokines, whereas IL-10 is a major anti-inflammatory cytokine. We have observed that both cortisol and catecholamines strongly inhibit, through receptor dependent-mechanisms, the secretion of TNF-alpha and IL-12, but cortisol does not significantly suppress secretion of IL-10, and catecholamines powerfully stimulate IL-10. Similar inhibitory or stimulatory effects were observed with histamine, acting through H2 receptors (Elenkov et al., J. Immunol. 161:2586, 1998). Histamine is released by mast cells stimulated by various mediators released by sensory nerves. Our studies on pregnant and postpartum patients are in progress but definitive data are not yet available. CONCLUSIONS: Our observations, demonstrating contrasting effects of these stress mediators, have important implications on our understanding of the role of neural and endocrine factors in the regulation of inflammatory processes. These data have relevance to numerous clinical disorders that are influenced by factors such as age, gender, reproductive status and stressful stimuli.